Orbitrap Mass Spectrometer

DESCRIPTION (provided by applicant): This application is a request for an LTQ-Orbitrap Velos ETD mass spectrometer to support new proteomics research efforts at Cold Spring Harbor Laboratory (CSHL). The instrument will be used to support multiple CSHL investigators in studies including phosphoproteome analysis in signal transduction, variability in protein splicing, characterization of protein complexes and large scale analysis of early brain development. The studies that will be enabled using the requested instrumentation are relevant to public health as they are directly linked to cancer or neurological disorders (autism). For example, analysis of protein complexes from the Lowe laboratory will be used to identify new components of oncogene and tumor suppressor gene networks and characterize their impact on tumorigenesis and treatment response. In collaboration with the Huang laboratory we propose to carry out a systematic proteomic study to characterize how brain protein expression profiles are altered in mouse models of Rett's Syndrome (autism). This type of large-scale, quantitative proteomics experiment has never been performed on site at CSHL due to lack of appropriate equipment. PUBLIC HEALTH RELEVANCE: On-site access to an Orbitrap Velos mass spectrometer will enable Cold Spring Harbor Scientists to perform large scale quantitative proteomic studies in a variety of research efforts directed at cancer and neurological disease. The requested equipment has superior mass accuracy, resolution and improved data collection rates when compared to previous generations. The equipment will be used for applications such as studying the effects of oncogene addiction (cancer), proteomic analysis in mice models of Rett's syndrome (autism) and translation initiation as a therapeutic target (cancer initiation and progression).